Understanding and Harnessing Microbial Reprogramming to Combat Carcinogenic Colibactin in Colorectal Cancer

Abstract
In alignment with the FOA PAR-22-085, which emphasizes microbial-based cancer therapies, our
objectives are twofold: (1) to develop a novel strategy to enzymatically inhibit colibactin, a procarcinogenic
metabolite from enteric bacteria associated with colorectal cancer (CRC), and (2) to understand how these
engineered microbes reduce the in vivo colonization of colibactin-producing bacteria but spare other microbes.
The rising incidence of colonization by pathogenic gut bacteria producing procarcinogenic molecules has
garnered increasing attention, with colibactin representing one of the most extensively studied microbial
metabolites linked to CRC. Colibactin induces DNA damage, senescence, and genomic mutations in the host
intestinal epithelium. Colibactin-producing bacteria carry the polyketide synthase (pks) gene island, and recent
studies have demonstrated a high prevalence of pks+ bacteria in 55–67% of CRC patients. Despite efforts to
understand the mechanisms underlying colibactin-induced CRC, few therapeutic strategies have been
developed to target colibactin directly. Interestingly, pks+ bacteria possess an intracellular resistance protein,
ClbS, which inactivates colibactin and shields the bacteria from colibactin-induced self-DNA damage. Inspired
by this natural defense mechanism, we hypothesize that engineering nonpathogenic living microbes to deliver
ClbS via bacterial surface display can safely and effectively inactivate colibactin in the gut. We base our
hypothesis on a synthesis of our recent publication and exciting preliminary data, demonstrating that (1) surface-
displayed ClbS prevents colibactin-mediated genotoxicity in cell lines and colon organoids of mouse and human
origins. (2) ClbS-displaying commensal E. coli reduces tumorigenesis in a colitis-associated CRC model infected
with pks+ bacteria without adverse effects. (3) ClbS-displaying E. coli inhibits pks+ bacteria but spares the
isogenic strains lacking the pks island in conventional mice containing the native gut microbiome.
While our preliminary data demonstrate an innovative solution to targeting colibactin through engineered
bacteria, it raises several questions to address mechanistically and therapeutically. Aim 1 will understand ‘if and
how’ ClbS-displaying commensal E. coli inhibits pks+ bacteria directly or indirectly by abrogating colibactin-
mediated niche competition with the gut microbiome. In parallel, Aim 2 will enhance mechanistic understanding
and translational potential by investigating how ClbS-displaying E. coli impacts the tumor initiation, progression,
colibactin-specific mutational signatures, and responses to immune checkpoint blockade in mouse CRC models.
The expected outcomes are (1) to elucidate the molecular mechanisms through which engineered E.
coli inhibits pks+ bacteria and neutralizes colibactin and (2) to offer a novel therapeutic approach to CRC
intervention. Although this work focuses on targeting colibactin in pks+ bacteria, a long-term goal of this proposal
is to engineer microbial therapeutics targeting other cancer-promoting bacterial metabolites via the bacterial
surface display in conjunction with the standard care of treatment for CRC.

Public health relevance
Project Narrative Effective treatments are needed for colorectal cancer (CRC), particularly those targeting carcinogenic bacterial metabolites. Colibactin is one of the deleterious metabolites produced by gut bacteria, and it has been linked to DNA damage, mutation, and tumor progression in CRC. This grant will investigate whether non-pathogenic colibactin-degrading commensal bacteria or probiotics can reduce the colonization of colibactin-producing bacteria, prevent CRC, and improve the effectiveness of immunotherapies.